Early Developmental Risk for Adult Cardiovascular Disease: High risk Subgroups, Biomarkers, and Mechanisms

This project seeks to generate new insights – of clinical and public/health/relevance – regarding
the early identification and prevention of adult coronary heart disease (CHD). It is well known
that 10% of infants born small for gestational age (SGA), compared to average for gestational
infants (AGA), are at increased risk for later life CHD and cardiovascular disease (CVD)
mortality. However, there is substantial heterogeneity in these findings and it is not clear: a)
which SGA infants are at elevated risk; and b) which underlying pathobiologic mechanisms are
implicated. Based upon our published work and those of others, we hypothesize that fetal
programming related to placental dysfunction, chronic fetal hypoxia, nutrient deprivation and
cardiac remodeling in some SGA infants results in cardiovascular and metabolic alterations and
subsequent increased CHD risk. Understanding which SGA infants are at elevated risk, and by
what mechanisms are critical steps to advance prevention efforts through targeted screening
and early intervention practices.
The New England Family Study (NEFS) is a prenatal cohort of 16,000 individuals now aged 57-
64 years, offspring of pregnant women enrolled in the Providence, RI and Boston, MA sites of
the NIH Collaborative Perinatal Project. Participants were recruited between 1959 and 1966,
prenatal and infant umbilical cord serum samples collected, and offspring assessed through the
first 7 years of life, providing a unique cohort to address these topics. Our multidisciplinary team
with an established collaborative track record proposes to complete comprehensive clinical
assessments of approximately 800 SGA infants from this cohort. We will be able to conduct this
60-year prospective project - with state-of-the-art adult cardiovascular assessments - based
upon 35 years fieldwork with this cohort and prior experience of clinical assessments with large
samples of community participants. Using banked maternal and infant sera, we will evaluate
prenatal (mother’s 3rd trimester) serum for markers of: a) placental dysfunction and impaired
vasculogenesis (placental growth factor (PIGF) and soluble fms-like tyrosine kinase-1
(SFLT-1) / PGIF ratio and b) metabolomics as evidence of maternal metabolic programming – in
relation to adult offspring CHD risk. Using cord serum samples, we will investigate evidence of
chronic fetal hypoxia (erythropoietin levels), lipids, and metabolomics as measures of metabolic
programming and fetal NT-pro-BNP and hs-TcNT-T as reflective of cardiac programming in
SGA infants – in relation to adult offspring CVD risk. Plans and implications detailed herein.
Project Summary/Abstract

Public health relevance
PROJECT NARRATIVE We have known for 30 years that the 10% of infants born small for gestational age, compared to average for gestational infants, are at increased risk for later life coronary heart disease (CHD) and cardiovascular disease (CVD) mortality. This one-of-a-kind 60-year longitudinal study seeks to understand why and to advance clinical and public health strategies to reduce this increased risk. It will identify and link biomarkers collected during pregnancy (in the 1960s) to sophisticated measures of heart function and disease among 800 adults now ages 60-65.